Analysis of intestinal genes regulated by the transcription factor CDX2

DESCRIPTION (provided by applicant): Appreciation of the molecular mechanisms responsible for intestine-specific gene regulation and cell differentiation is limited. One important regulator, the transcription factor CDX2, is restricted to intestinal epithelium, where it is expressed throughout the crypt-villus unit and required in vivo for differentiation of gut- specific columnar epithelium. Knowledge of CDX2's transcriptional targets and mechanisms is incomplete, as is understanding of how it functions as a master transcriptional regulator. We have used whole-genome chromatin immunoprecipitation (ChIP) to identify, with high confidence, regions of CDX2 occupancy in colonic epithelial cells. CDX2-binding regions are highly conserved and show significant clustering of motifs for a handful of other sequence-specific DNA-binding proteins previously implicated in intestinal gene regulation. Our studies hence correctly identify numerous CDX2 targets and reveal 3 specific candidate partner transcription factors in intestine-specific gene regulation. We will extend the preliminary data and insights to test specific hypotheses on CDX2 function and molecular mechanisms. Aim 1 seeks to identify which among ~1,100 CDX2-binding sites are bona fide cis-elements in intestine cells. We will identify transcripts that respond to CDX2 depletion in cells that express the factor and to forced CDX2 expression in cells that don't. We will also test putative cis-elements in functional reporter assays and critically examine whether CDX2 target genes reflect the activities expected of a master regulator. Unexpectedly, we find that CDX2 commonly occupies DNA very close to binding sites for Tcf proteins, transcriptional effectors of the canonical Wnt pathway. Wnt signals are transmitted in many tissues but are critical in intestinal homeostasis. We will test the novel hypothesis that CDX2 imparts intestinal specificity within a global Wnt response. We also find significant co-occupancy of the nuclear receptor HNF4) near CDX2-activated genes and of GATA proteins near genes that CDX2 appears to repress. Aim 2 takes several approaches to test the hypothesis that HNF4) and GATA factors combine with CDX2 to activate and silence genes, respectively. Lastly, genome-wide ChIP on isolated mouse intestinal crypt and villus fractions implies that Cdx2 controls distinct genes within these two functional compartments. In Aim 3 we will test this hypothesis and address the underlying mechanisms. We will delineate Cdx2 partner proteins and ask if Cdx2 binding is needed to generate crypt- and villus-specific chromatin domains or, conversely, if Cdx2 responds to the creation of such domains by other factors. To this end, we have established the feasibility of whole-genome analysis of informative chromatin marks and generated mice in which intestinal Cdx2 levels can be modulated. These studies represent a detailed and comprehensive approach to elucidate mechanisms of intestine-specific gene regulation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Common disorders of the gastrointestinal (GI) tract, including inflammation, malabsorption, ulcers and cancer, cause considerable suffering and death. Although these conditions are fundamentally related to mechanisms of normal gene expression and cell behavior, there is limited appreciation of their molecular underpinnings. The CDX2 protein, which is found almost exclusively in the intestine, is a pivotal regulator in normal and disease states. Investigation of its regulatory functions will improve understanding and, ultimately, treatment of many common GI diseases. PROJECT NARRATIVE Common disorders of the gastrointestinal (GI) tract, including inflammation, malabsorption, ulcers and cancer, cause considerable suffering and death. Although these conditions are fundamentally related to mechanisms of normal gene expression and cell behavior, there is limited appreciation of their molecular underpinnings. The CDX2 protein, which is found almost exclusively in the intestine, is a pivotal regulator in normal and disease states. Investigation of its regulatory functions will improve understanding and, ultimately, treatment of many common GI diseases. __SpecificAimsTextDelimiter__ RESEARCH PROPOSAL A. SPECIFIC AIMS Gut epithelium serves diverse functions in digestion, absorption, secretion, and metabolism. We seek to investigate the molecular basis for these diverse functions through the role of the transcription factor (TF) CDX2, a pivotal regulator of gut epithelial identity. Using chromatin immunoprecipitation (ChIP) followed by hybridization of precipitated DNA fragments to whole-genome microarrays (chips), we have obtained robust ChIP-chip data on sites of CDX2 interaction with the genome of human gut epithelial cells. The results present new avenues to study molecular mechanisms of intestinal gene regulation. Aim 1: To delineate CDX2's specific interactions with the intestinal epithelial cell genome and its major partner transcriptional regulators, and to test the hypothesis that CDX2 combines with Wnt signaling, a prominent regulator of gut epithelium, to regulate tissue-specific gene expression. Although Cdx2 is a critical regulator of gut epithelium, few of its transcriptional targets are known. ChIP- chip analysis permits accurate, high-resolution mapping of TF interactions with target genes and we have identified ~1,100 short genomic regions that CDX2 occupies in Caco-2 human gut epithelial cells. We will determine the significance of the CDX2 "cistrome" in regulation of neighboring genes and study how candidate cis-elements relate to intestine-expressed genes. We find unexpected clustering of sites that bind CDX2 and those that bind TCF4, a key transcriptional effector of Wnt signaling, and will test the hypothesis that this TF combination is particularly important in intestinal gene regulation. Aim 2: To decipher the roles of prominent TFs that partner with CDX2 in intestine gene regulation and to test the hypothesis that CDX2 combines with HNF4α to activate intestinal genes and with GATA proteins to silence gene expression. Our studies reveal that cis-elements specific for HNF4α and GATA proteins, two TF sub-families highly expressed in the intestine, are significantly enriched near CDX2-occupied sites in Caco-2 cells, a result we validated experimentally. Mice deficient in these factors have intestinal defects, supporting the likelihood of combinatorial gene regulation. Unexpectedly, CDX2- HNF4α and CDX2-GATA site pairings occur asymmetrically in activated and repressed genes, respectively. We will test the hypothesis that these pairings are significant for intestine-specific gene expression and also examine the underlying mechanism with respect to TF recruitment onto DNA. Aim 3: To extend analysis of the CDX2 cistrome from cultured cell lines to live intestinal tissue and hence determine CDX2 functions and mechanisms in physiologic contexts. Although studies in cultured cell lines are highly informative, it is important to determine CDX2 function in the native intestine, where it is expressed in both villi and undifferentiated crypt precursors. We have used ChIP to characterize Cdx2 binding in mouse gut epithelium and will critically test the hypothesis that it regulates distinct sets of genes in these two cell compartments. We will also determine whether Cdx2 partners with the different TFs to regulate gene expression in intestinal crypts and villi, and ask if Cdx2 establishes permissive chromatin domains or responds to chromatin modifications induced by other factors. Understanding of CDX2 target genes has heretofore relied on generalizing from isolated examples; genome-wide analysis provides unbiased, accurate and, ultimately, fuller perspective. Building on a reliable genome-scale dataset, this proposal addresses outstanding questions that lie at the heart of gut epithelial function and disease. Our purpose is not just to generate a list of CDX2 transcriptional targets, which on its own would provide limited insight. Rather, we will test specific and cogent hypotheses that will expose novel facets and mechanisms of gene expression and differentiation in intestinal epithelium. Abbreviations and uncommon terms used in this proposal Cdx, Caudal-type homeobox; CEAS, Cis-regulatory Element Annotation System, a computational tool for genome-wide cis-element studies; ChIP, chromatin IP; "cistrome", the set of genomic sites (putative cis-elements) bound by a protein; FDR, false discovery rate, a statistical measure of specificity in genomic studies; IP, immunoprecipitation; ISH, [RNA] in situ hybridization; LM-PCR, ligation-mediated PCR; MACS, Model-based Analysis of ChIP-seq; MAT, Model-based Analysis of Tiled Arrays; MGPD, Mouse Gene Prediction Database; TF, transcription factor.